Promoting Implementation of Behavioral Classroom Interventions for Children with ADHD in Urban Schools

PROJECT SUMMARY
Schools are an accessible and ecologically valid setting for children with ADHD to receive evidence-based
interventions to reduce symptoms and improve functioning. Behavioral classroom management interventions
are well-established treatments for elementary-school age children with ADHD. Randomized trials of
behavioral classroom management interventions demonstrate that they decrease disruptive behavior
symptoms and improve academic outcomes for children with ADHD. Teachers' implementation of these
practices is often lower than recommended standards. Our preliminary work suggests that in the demanding
context of under-resourced public schools, even when teachers intend to implement EBPs, they often struggle
to do so. As such, it is important to understand and target both factors that promote teachers' intentions to
implement EBPs, as well as those that promote their ability to act on their intentions. This K23 application
proposes to iteratively develop and pilot test a set of key implementation strategies that promote teachers'
implementation of behavioral classroom interventions for children with symptoms of ADHD. The research plan
will address three specific aims: (1) Use observations, interviews, and surveys to examine malleable
determinants of teachers' use of behavioral classroom interventions for children with ADHD symptoms; (2)
Partner with community stakeholders to iteratively develop and refine a resource package of key
implementation strategies to promote teacher use of behavioral classroom management interventions; (3) Pilot
test the implementation strategy resource package to demonstrate feasibility in a small-scale Type 3 Hybrid
Trial. The primary outcomes of the pilot study will be acceptability, appropriateness and feasibility, observed
teacher use of behavioral classroom management interventions, and child ADHD symptoms and functional
impairment. The research proposal supports a training plan to increase the PI's expertise in three areas: (1)
School-based interventions for ADHD; (2) Developing tailored implementation strategies using mixed-methods;
and (3) School-based hybrid implementation-effectiveness trials.

Public health relevance
PROJECT NARRATIVE This application proposes to enhance the provision of behavioral classroom management interventions for elementary-school children with ADHD, an evidence-based practice that is currently underutilized. The mentorship, training, and research activities will improve the applicants' expertise in the implementation of evidence-based practices for ADHD in school settings, and will inform future implementation efforts. The present study has the potential to impact public health by encouraging more effective implementation of evidence-based treatments for ADHD in school settings.